NASDA Foundation and AAAFCO, Long-Term Improvements to the National Animal Food Safety System and Promotion of the Animal Feed Regulatory Program Standards (AFRPS)

PROJECT SUMMARY
Project Title: Long-Term Improvements to the National Animal Food Safety System Through
Integration, Strengthened Collaboration, Improved State Regulatory and Surveillance Protection
Programs, and Promotion of the Animal Feed Regulatory Program Standards
Project Objectives: As outlined in the requirements for RFA-FD-22-009, our primary objectives for this
proposed project are for the NASDA Foundation (NASDAF) and AAFCO to:
1. Continue to collaboratively support federal and state efforts to build and expand a national
integrated animal food safety system;
2. Establish improved systems for sharing, promotion, and collaboration of best practices,
guidance documents, sampling plans, procedures, memorandums of understanding, and other
tools to facilitate and encourage mutual reliance between federal and state animal food
regulatory programs and public health agencies;
3. Continue to identify, develop, deliver, promote, and support animal food safety training
programs that further implementation of the AFRPS and provide stakeholder support for the
animal food provisions of FSMA; and
4. Continue to support the advancement of the AFRPS and future revisions of the AFRPS as part of
a system of continuous improvement to ensure the standards are modernized and support the
requirements of FSMA and the needs of animal food regulatory programs.
Expected Outcomes: The work outlined in this proposal will continue to build upon past successes
achieved by the collaboration between national associations and state and federal partners over the
past seven years, resulting in continuous improvement of the national integrated animal food safety
system and increased compliance with the AFRPS. Additionally, by working under a single cooperative
agreement, administrative cost savings will be realized by FDA, NASDAF, and AAFCO.

Public health relevance
PROJECT NARRATIVE Project Title: Long-Term Improvements to the National Animal Food Safety System Through Integration, Strengthened Collaboration, Improved State Regulatory and Surveillance Protection Programs, and Promotion of the Animal Feed Regulatory Program Standards Under an initial 5-year cooperative agreement from FDA, considerable progress has been made toward modernization of the national animal food safety system as envisioned by the Food Safety Modernization Act (FSMA). The work outlined in this project proposal will continue the important joint efforts of AAFCO, NASDA, and FDA as they work together on continuous improvement of the national animal food safety system and promotion of the Animal Feed Regulatory Program Standards (AFRPS).